Dissemination and Implementation of an Evidence-Based Pediatric Weight Management Program for Use by Low-Income Families: A User-Friendly Package of Family-Based Behavioral Treatment

Project Summary
Family-based Behavioral Treatment (FBT) is an evidence-based pediatric weight management intervention
(PWMI) that targets both child and parent. More than 30 years of research indicate that FBT reduces children’s
percent overweight by almost 20%, with the average parent losing about 20 pounds during treatment. FBT also
meets the US Preventive Services Task Force Recommendations as a comprehensive treatment for childhood
obesity delivering more than 26 contact hours. The proposed project brings together a multi-sector team of
collaborators, with expertise in behavioral science, community-based implementation science, pediatrics,
technology, health services, and health economics. This multi-sector team will package and pilot test FBT for
the treatment of pediatric obesity in two sites, representing both rural and urban settings, towards the goal of
increasing access to this evidence-based, effective treatment among low-income families with children ages 5
to 12. First, training and treatment will be packaged for dissemination in a turn-key, technology-
enhanced format (Aim 1). Given the lack of certified health care providers who can deliver FBT--which
creates a major treatment barrier for low-income populations--we will develop the first online FBT training
platform that includes FBT training materials for interventionists and treatment support materials for families.
To inform this digital treatment package, we will incorporate feedback from a broad range of stakeholders,
including representatives from local community-based organizations that serve low-income families, health
care providers, local provider organizations, and members of the target populations. Once packaged, the
intervention will be implemented in two distinct primary care settings (rural and urban; Aim 2). Primary
care offers an optimal setting for FBT delivery, as it capitalizes on the established relationship between primary
care providers and families. Co-locating interventionists within the primary care setting overcomes
fragmentation of care and addresses provider time and referral barriers. Further, this delivery strategy dovetails
with Missouri HealthNet Division’s recent state plan amendment which is scheduled to take effect in Missouri in
2019 to cover intensive obesity behavioral counseling and medical nutrition therapy for Medicaid patients, thus
setting the stage for scaling FBT implementation across primary care. Implementation outcomes of the
packaged intervention will be assessed at the organizational-level (Aim 2A) and patient-level (Aim
2B). Additionally, a scheduled Medicaid reimbursement mechanism will be evaluated as a promising method
for sustainability and can serve as a model for other reimbursement mechanisms for private and public payers
across the nation. Finally, the packaged treatment will be optimized based on data and feedback from
the study, and community partners will be engaged to develop a sustainability and dissemination plan
(Aim 3). Establishing that FBT can be implemented in real world settings is crucial to creating a system where
children and their families affected by obesity can be effectively treated in centralized primary care settings.

Public health relevance
Project Narrative This pragmatic project will package and evaluate the implementation of the evidence-based Family-based Behavioral Treatment (FBT) for childhood obesity in rural and urban primary care settings for low-income families. Co-located interventionists will deliver care within primary care settings, supported by a turn-key, technology-enhanced FBT training platform that includes not only FBT training materials for interventionists but also treatment support materials for families. Provider, patient, and organizational-level outcomes will be evaluated to achieve the goal of optimizing a FBT treatment package that can be implemented into primary care settings in a sustainable, cost-effective manner and support public health priorities of reducing morbidity and mortality related to overweight and obesity.